EVALUATION OF SQ32,756 IN IMMUNOCOMPROMISED PATIENTS

The purpose of this study is to compare BV-araU to the standard therapy, acyclovir, for the treatment of varicella-zoster infections (shingles) in patients who are immunocompromised.